CENTER CORE GRANT FOR VISION RESEARCH

The NEI P3O Center Core Grant for Vision Research at the University of Houston provides
ongoing and stable funding for four high quality and productive vision research resource/service
Modules: Instrument Design, Research Computer Programming, Biostatistics Support, and
Biological Imaging. These Modules are directed by established vision scientists with NEI funding,
and run by an exceptionally talented staff with considerable long-term experience in supporting
and advancing innovative vision research at the University of Houston. The Modules provide
needed research resources and services, with prioritized and equitable access, to the present
group of 22 Core vision scientists who come from three departments at the University (Biomedical
Engineering, Vision Sciences and Clinical Sciences in Optometry). These Core vision scientists
have diverse training and research interests; they collaborate effectively with one another, as well
as with more than 100 other vision researchers at this University or other institutions. Together,
11 of our Core investigators hold 10 active NEI R01 grants, with some other core investigators as
Co-Is, as well as other NEI funding, NIH and nonfederal vision research funding. The College of
Optometry and University of Houston provide substantial additional commitments in support of
vision research. During the past five years of P30 funding at this University, the Core Grant has
created a favorable vision research environment, including new instrumentation and core
collaborative arrangements, that have contributed directly to 137 out of 230 published papers by
Core investigators and supported the addition of eight investigators, established and new, to the
Core group of vision scientists, four of whom brought or quickly secured NEI funding. The Core
modules also were important to obtaining new NEI funding for a multicenter clinical trial. These
accomplishments reflect the Core's previous and current aims reinforced by the oversight of the
Administrative Core, that focus on advancing collaborative and innovative basic, translational and
clinical research to increase knowledge and prevent or cure disease. Through these aims the
Core grant provides stable funding, quality research services, new vision researchers, and new
projects attracting NIH and NEI support. Especially emphasized in the coming five years will be
innovative research basic, translational and clinical research and recruitment of vision
researchers to fill our current open positions, as well as other positions in the future.

Public health relevance
The Center Core Grant for Vision Research at the University of Houston increases knowledge about the structure and function of the visual system, and improves visual health by supporting investigators in individual labs, and in collaborations across labs and disciplines, in doing basic, translational and clinical research on vision and vision disorders.